Recovery of language and theory of mind after stroke

Project Summary
Left and right hemisphere (RH) strokes occur at similar frequencies and both are associated with life-altering
communication deficits. However, patients with RH stroke rarely receive speech-language intervention, likely because
they do not present with obvious language deficits like aphasia. Instead, they have difficulties engaging in typical
conversations which require understanding what a speaker means, especially when in opposition to what was actually
said, such as occurs in sarcasm, humor and metaphors. A specific deficit in the ability to understand others’ perspectives
and intended meanings, known as theory of mind (ToM) may be a primary cause of communication deficits and a
critical component of differential recovery after RH stroke. Inappropriately responding during conversation due to
misunderstandings of what a speaker knows and intends creates poor social interactions and negatively impacts
relationships. For those living with RH stroke, communication deficits have profoundly damaging effects on quality of
life. Our central hypothesis is that RH stroke causes discourse-level language deficits due to damage to brain areas
critical to ToM, an essential component of social communication. Our goal is to assess language and ToM abilities from
acute to chronic stages of RH stroke while collecting neuroanatomical and quality of life data. We will measure the
contribution of other social deficits including the processing of emotional prosody and non-verbal cues (e.g., facial
expressions) as well as cognitive deficits including working memory, executive function, and attention. To date,
estimates of language and ToM deficits which occur after RH stroke and the relationship between them are inconsistent
or unexplored. Most studies examine patients in rehabilitation settings who likely have large strokes and more severe
communication disorders, creating a bias in our knowledge about the effects of stroke. The effects of damage to RH
brain regions, their connections, and how they contribute to language recovery are also unknown, limiting decisions
about treatment priorities. Lastly, whether language recovery depends on ToM is unknown as there are no longitudinal
studies of communication recovery from acute RH stroke. We will address these gaps by examining individuals in a large
group of acute stroke subjects, as they progress from acute to chronic stroke to evaluate the relationship between
changes in language, ToM and their dependence on neural recovery. Our innovative approach combines recent
advances in neuropsychological testing and neuroimaging analysis to provide converging causal evidence to validate a
ToM theory of RH stroke communication. Aim 1 tests the hypothesis that language depends on intact ToM at the acute
stage of stroke before functional reorganization. Aim 2 tests the hypothesis that language depends on ToM associated
neural structures and connectivity acutely, before functional reorganization. Aim 3 examines recovery of language and
relationships with ToM and brain structure by assessing behavioral and neural changes across the first year after stroke.
Successful outcomes include understanding the behavioral and neural mechanisms underlying RH deficits, their
evolution post-stroke, and their impact on quality of life. As a result, we will be able to develop better assessment and
intervention tools, improving access to health care and long-term outcomes for this underserved patient population.

Public health relevance
Project Narrative: Relevance to Public Health This project examines how cognitive abilities impact the recovery of language in individuals during the acute to chronic stages of stroke. Assessing these abilities over time while collecting neural information will enable us identify patterns of co-occurrence to gain predictive power about what types of brain damage and behavior lead to chronic communicative loss. As a result, we will be able to provide a clear path to improved diagnosis and treatment of communicative difficulties following right hemisphere stroke.